Sequential Multiple Assignment Randomized Trial to Reduce Food Insecurity and Improve Adherence in Patients with Hypertension

Project Summary/Abstract
Food insecurity (FI) affects 20% of the 116 million people in the US with hypertension (HTN). FI is associated
with poor adherence to evidence-based HTN treatments, worse blood pressure control, and a higher risk of
mortality. Interventions used to address FI in clinical care settings include 1) providing information about
community resources, 2) utilizing community health workers, and 3) delivering medically-tailored meals.
Although there is evidence for each of these interventions, people differ in the support they need to reduce FI
and little is known about which interventions work best, or for whom. Rather than use a single FI intervention,
adaptively allocating interventions could be a more effective, equitable, and efficient approach to improve food
security, treatment adherence, and blood pressure for the large, vulnerable population affected by FI and HTN.
Our objectives are to 1) determine which initial FI intervention more effectively improves adherence and blood
pressure and 2) for those who do not respond to the initial intervention, evaluate how best to provide additional
support. We will conduct a Sequential Multiple Assignment Randomized Trial (SMART) in partnership with
Atrium Health Wake Forest Baptist, an academic medical center that serves communities in North Carolina
with high rates of FI and HTN. In the SMART, patients with uncontrolled HTN and FI will be randomized to 1 of
2 first-stage FI interventions: 1) resource information or 2) community health worker support. Participants who
do not have an improvement in blood pressure after 3 months will be re-randomized to 1 of 2 second-stage
interventions for an additional 3 months: 1) community health worker support or 2) medically-tailored meals.
In Aim 1, we will determine which first-stage FI intervention is more effective in improving adherence and blood
pressure. In Aim 2, we will evaluate which FI intervention is the best next step for those who do not respond to
the initial intervention. In Aim 3, we will explore how, why, and under what circumstances participants achieved
improvements to the first- and second-stage interventions by conducting semi-structured interviews with
participants and evaluating for potential predictors of heterogeneity in response to each intervention.
The proposed research complements NHLBI’s NOSI (NOT-OD-21-100) to “overcome barriers to adherence to
evidence-based guidelines” and “address social determinants that contribute to disparities in adherence.” This
will be the first study to evaluate an adaptive intervention to enhance adherence to HTN treatments, by
addressing FI. Given the growing interest among health systems in addressing FI as part of clinical care, an
efficacious adaptive intervention could be broadly disseminated across healthcare settings. An adaptive FI
intervention could reduce the costs and burden to patients and providers by providing no more treatment than
is needed for patients who respond to a less intensive approach and redirecting the saved resources to
patients who need a more intensive approach. Our team of established investigators has successfully used the
methods proposed and has the full support of the health system where the study will occur.

Public health relevance
Project Narrative Food insecurity affects 20% of the 116 million people in the US with hypertension and is associated with poor adherence to evidence-based treatments and disparities in hypertension outcomes. Interventions are being used to address food insecurity in clinical care settings, but people differ in the support they need to reduce food insecurity and little is known about which food insecurity interventions work best, or for whom. The goal of this study is to develop and test an adaptive food insecurity intervention using a Sequential Multiple Assignment Randomized Trial to determine which initial food insecurity intervention is more effective in improving adherence and blood pressure in patients with hypertension and for those who do not respond to the initial intervention, evaluate how to best provide additional support.